EXERCISE TO PREVENT DECONDITIONING IN SPACEFLIGHT

Determine if 40 minutes of supine treadmill running per day in a lower body negative pressure (LBNP) chamber at 1.0 to 1.2 body weight with a 5 minute resting, non-exercise LBNP exposure after the exercise session will maintain aerobic fitness, orthostatic tolerance and musculoskeletal structure and functioning during 30 days of bed rest (simulated microgravity).